Testing Adaptive Interventions to Improve PTSD Treatment Outcomes in Federally Qualified Health Centers

Project Summary/Abstract
Posttraumatic stress disorder (PTSD) is a debilitating psychiatric disorder that affects 6% of U.S. adults, yet is
left untreated in 70% of affected individuals and up to 85% of low-income individuals. One third of the nation’s
low-income individuals are treated in Federally Qualified Health Centers (FQHCs), which do not have the
capacity to provide all their patients with first-line, evidence-based treatments for PTSD such as Prolonged
Exposure (PE). To address this problem, the study team has developed a low-intensity intervention (PTSD
Coach) and a medium-intensity intervention (PE for Primary Care: PE-PC) that effectively treat PTSD in low-
resource settings. However, some patients will still require high-intensity treatments (e.g., Full PE) for
sustained clinical benefit. Thus, there is a critical need to develop adaptive, stepped-care models to treat PTSD
in FQHCs by combining efficacious treatments, based on response to initial lower-cost strategies. The long-
term goal of this line of research is to improve access to efficacious PTSD treatments by implementing
empirically-based stepped-care behavioral interventions in low-resource domestic settings. The overall
objective in this proposal is to develop a stepped-care intervention for PTSD using a Sequential, Multiple
Assignment, Randomized Trial (SMART). The central hypothesis is that beginning with a low- or medium-
intensity PTSD intervention and then titrating intensity based on early indications of response will result in
clinically-significant PTSD symptom reduction with parsimony of resources. The rationale is that stepped-care
interventions for PTSD are scalable and less costly than static treatments, thereby improving efficiency. To
accomplish the objective, this project will employ a SMART design with 430 adults with PTSD in six FQHCs.
Participants will be initially randomized to PTSD Coach or PE-PC. After four weeks, early responders will step
down to lower frequency interaction within their current treatment strategy. Slow responders will be re-
randomized to either continue their current treatment strategy or step up to Full PE for eight weeks. The
specific aims are to: (1) Test the effectiveness of initiating treatment with PE-PC versus PTSD Coach in
reducing PTSD symptoms at 3 months (endpoint), 6-month follow-up and 9-month follow-up, and (2) Test the
effectiveness of second-stage tactics (continue or step up to Full PE) for slow responders. Exploratory aims
are to (A) Identify the optimal stepped-care treatment sequence; (B) Conduct cost-effectiveness analysis; (C)
Identify key mediators/moderators of treatment response; and (D) Prepare for future implementation through
process evaluation. This project will contribute to the field an empirically-based stepped-care intervention for
PTSD. This contribution is significant because it will improve clinical practice for PTSD by establishing an
effective treatment sequence that can be delivered in a scalable, sustainable manner. This proposal is
innovative because it will use novel methodologies to help shift the current clinical paradigm of PTSD treatment
from fixed, static, and hard-to-access treatment strategies to a dynamic, adaptive, and accessible approach.

Public health relevance
Project Narrative The proposed project is relevant to public health because it will develop a stepped-care intervention for PTSD that can be readily applied in real-world practice and community settings, thus helping to expand access to efficacious treatment among underserved individuals. This innovative approach will improve the scalability and efficiency of PTSD treatment by reducing costs while maximizing effectiveness. It is relevant to the NIMH’s mission to test bundled, validated intervention components that have the greatest impact on patients’ functioning.